Administrative Supplement to 1 UG3 NS106938-02: “NIBA-TBI: Neuro-Imaging and biofluid-based Biomarker Assessments as translational pathophysiological outcome measures in TBI

Summary / Abstract (Administrative Supplement) Consistent with the vision of the Translational Outcomes Project in Neurotrauma (TOPNT) (UG3/UH3) RFA, we assembled a multidisciplinary team and proposed to evaluate two complementary pathological mechanism- based TBI outcome measures – (i) biofluid biomarker assessment, and (ii) MRI-neuroimaging biomarker assessment. The objective of this administrative supplement is to facilitate cross-site harmonization and validation of neuroimaging and biofluid-based biomarker methods across the 4 funded study centers. We have the following supplementary aims: Supplementary Aim A1: To develop and optimize a multiparametric MRI protocol that completely meets needs for all labs in the consortium and to determine cross-lab measurement reproducibility on MRI calibration phantoms, live healthy control rats, and ex vivo rat brains. Supplementary Aim B1- Subject purified rat, and/or mouse and human GFAP and their calpain and caspase-digest to different measurement assays using western blot, ELISA and mass spectrometry at the two UG3 TOP-NT biomarker lab (UCLA, and UF). Supplementary Aim B2- At both UF and UCLA sites, terminal animal biosamples (control, injured) will be examined with the above GFAP assay approaches.

Public health relevance
Narrative Consistent with the vision of the Translational Outcomes Project in Neurotrauma (TOPNT) (UG3/UH3) RFA, we assembled a multidisciplinary team and proposed to evaluate two complementary pathological mechanism-based TBI outcome measures – (i) biofluid biomarker assessment, and (ii) MRI-neuroimaging biomarker assessment. The objective of this administrative supplement is to facilitate cross-site harmonization and validation of neuroimaging and biofluid-based biomarker methods across the 4 funded study centers.